Aptamer specific for myeloid derived suppressor cells for the diagnosis of head and neck cancer from the oral rinse

The development of sensitive and specific diagnostic assays for the early detection of Head and Neck Cancer is
still an unmet medical need. Most assays being developed rely on a neoplastic cell biomarker often present in
only a proportion of neoplastic cells and/or a subset of patients with Head and Neck Squamous Cell carcinoma
(HNSCC). As such, the intrinsic heterogeneity of the neoplastic cell within a single patient and across patients
de facto limits the sensitivity of these assays. To overcome this problem, we propose to monitor HNSCC
presence in the oral rinse using RNA aptamers that recognize tumor-infiltrating myeloid cells. These cells
infiltrate the lesion in high numbers and early during tumorigenesis, participate in tumor initiation and
progression, and predict recurrence in HNSCC. Additionally, these cells are quickly renewed in the tumor
microenvironment and release their content in the tumor microenvironment and nearby fluid.
We identified four RNA aptamers that recognize myeloid derived suppressor cells and macrophages in the
HNSCC tumor but not the myeloid counterparts in the blood or healthy tissues in all patients evaluated.
Additionally, our feasibility and proof of principle experiments indicate that these aptamers might discriminate
oral rinses of patients with head and neck cancers from those of healthy donors. We propose to test the
hypothesis that MDSC-specific aptamers used in linear surface plasmon resonance (LSPR) experiments can
detect HNSCC from the oral rinse with high sensitivity and specificity. We will first optimize the assay using
samples already banked in our institution. Then, we will perform a prospective clinical study in which we will test
oral rinses from 150 patients with biopsy-proven HNSCC (all stage, all sites) and 150 age-matched healthy
donors. In particular, we will compare side-by-side the sensitivity and specificity of LSPR assays using as ligand
either our MDSC specific aptamers or an antibody against CD44, a marker strongly associated with HNSCC that
is being developed for HNSCC diagnosis from the oral rinse with promising results.
In summary, we propose a novel approach for the early diagnosis of HNSCC, a disease often diagnosed only
in advanced stages when the prognosis is poor, and the treatment morbidity is high. Should our hypothesis be
true, we anticipate that assays based on the presence of MDSC may aid in detecting this malignancy at earlier
stages when treatments are most effective and less invasive.

Public health relevance
Project narrative While most of the tumors in the head and neck region can be cured when discovered early, treatments are often ineffective when these tumors are discovered late. Since most head and neck cancers are found late, only when they become symptomatic, there is a need for non-invasive diagnostic tests to detect them early. We propose to develop a test able to discover the tumor from the oral rinse by checking for the presence of part of cells called myeloid derived suppressor cells that are present only in the tumor and that cancer needs to develop.